Administrative supplement to expand cancer clinical trial capacity in sub-Saharan Africa

SUMMARY
This application is being submitted in response to Notice of Special Interest (NOSI) NOT-CA-24-039.
Given the rising incidence and poor outcomes associated with cancer in Nigeria and surrounding
countries, the Nigerian Ministry of Health has designated cancer as a priority area for research and
training. To support this, we propose a new training program – the Nigerian Cancer Research Training
(NCAT) program – with the goal of increasing capacity for cancer research in Nigeria. We seek to not
only strengthen the existing research enterprise but to build in-country expertise and provide a solid
foundation for the development, implementation, and dissemination of evidence-based interventions
that will impact public health policy and cancer outcomes. The NCAT program builds on existing
relationships and infrastructure between Memorial Sloan Kettering Cancer Center (MSK), Obafemi
Awolowo University (OAU), and the College of Medicine/Lagos University Teaching Hospital
(CMUL/LUTH). We will employ a multi-level approach to strengthen research capacity for individuals
(Aim 1) and institutions (Aim 2), while also enhancing broader relationships at national, regional, and
global levels (Aim 3). The NCAT program will address two distinct needs for cancer research training
in Nigeria: 1. a training program that can be used for clinical faculty (primarily physicians and nurses)
that will not interfere with clinical/research duties, and 2. a training program to bolster the capacity of
full-time PhD-level researchers in the disciplines of cancer epidemiology, behavioral sciences, and
biostatistics. Trainees will be competitively selected, and we will emphasize diversity and
underrepresented specialties (e.g., nursing, psycho-oncology). A multi-pronged training approach,
utilizing coursework, “hands-on” research in ongoing breast and colorectal cancer studies, virtual
learning, mentorship, and collaboration will be used to train a cadre of multidisciplinary Nigerian cancer
researchers. After a one-year cancer research training period, NCAT trainees will be grouped into
research teams and take part in team science-based training, which will include designing and
conducting a collaborative mentored pilot research project in Nigeria. In addition, to enhance support
for local researchers beyond the project period, we will develop cancer research training courses to be
used in Nigeria, and provide mentorship and training to research administration offices at OAU and
CMUL/LUTH. We will use multiple layers of trainee and project assessment to ensure that our program
is meeting its ultimate goal of creating well-trained colorectal and breast cancer researchers and a
sustainable pipeline for continued cancer research in Nigeria. A supplemental award will address the
need for clinical trials expertise and design/analytic support through development of a clinical trials
workshop and a 6-month cancer biostatistics course, both to be conducted on an ongoing basis.

Public health relevance
NARRATIVE The burden of cancer in Nigeria, Africa’s most populous country, is large and growing, and there is a need for increased research capacity to generate evidence to inform effective treatments, cancer control programs, and policies. To meet this need, we will leverage a highly successful research partnership between Memorial Sloan Kettering Cancer Center (US), Obafemi Awolowo University (Nigeria), and the College of Medicine at the University of Lagos (Nigeria) to establish an international research training program aimed at creating a cohort of highly skilled Nigerian investigators able to lead independent oncology research programs, fostering team science, bolstering research administration capacity in Nigeria, and creating long-term research partnerships between Nigerian and US cancer researchers.